Exploiting Natural Killer cells in HIV/HBV co-infection to achieve eradication

Exploiting adaptive NK cells in HIV/HBV co-infection towards eradication
Project Summary/Abstract
Despite the benefits of combined antiretroviral treatment (ART) with dual activity against HIV
and HBV, the differences in outcome between HIV/HBV co-infected and HBV mono-infected
populations still persist. Our current understanding of the degree of immunological recovery
with therapy in these two groups, in particular in terms of hepatic immune responses is scarce,
identifying a significant knowledge gap and a barrier to the development of effective functional
cures. Recent technical advances, including the use of single-cell RNA sequencing (scRNA-
seq) and high-throughput single cell analysis along with fine needle aspirates (FNAs) of the
liver from appropriately matched clinical cohorts provide new exciting opportunities to probe
hepatic versus peripheral immune signatures. These innovative approaches will be applied to
ascertain the transcriptional landscape, proteomic and functional features of immune cell
populations in the liver and peripheral blood between HIV/HBV co-infected versus HBV mono-
infected patients at an entirely new level of resolution. Particular emphasis will be placed on
Natural Killer (NK) cells with adaptive properties and unique subpopulations of NK cells with
‘memory’ features enriched in the liver. These specialised subpopulations that arise in
response to chronic viral infections and following vaccination with HIV-encoded envelope
protein and endowed with enhanced functionality hold tremendous potential for effective
control of virus replication. Therefore, clinical exploitation of adaptive NK cells represents a
transformative approach to augment therapy of chronic viral infection. We aim to develop a
robust and scalable platform for the expansion of adaptive NK cells with enhanced
functionality and predictable selectivity that could circumvent many of the limitations inherent
to the various immunotherapeutic approaches tested so far, representing a novel avenue for
new or complementary curative strategies.

Public health relevance
Project Narrative In depth immunological studies of clinical material (blood and liver) to evaluate immune pathways/interplay between key immune cell populations in co-infected vs. HBV mono- infected patients and selective harnessing of adaptive NK cells to effect a functional cure.